Impact of Improving Footwear Options for Women Veterans with Amputations

Women with amputations receive more frequent prosthetics care, but are less satisfied with the fit,
comfort, and appearance of their prostheses than men. These findings are not surprising as most
prosthesis components are not gender-specific and seem to have been designed for men. Components
like prosthetic feet are made from molds, and it is prohibitively expensive for prosthetics companies to
provide a high number and variety of foot shape options.
Recent surveys indicate that women Veterans with leg amputations are unable to wear many of the
types of footwear they desire to wear due to limitations of the prosthetic foot. Women Veterans who
have greater perceived challenges with how their prosthesis affected footwear options also experienced
significantly more body image concerns and participated less in daily activities.
This project will assess the impact of a new prosthesis system including a modular prosthetic ankle that
can be used interchangeably with several 3D-printed feet. The prosthetic feet are customized to fit a
wide range of footwear, including shoes of different heel heights and widths. To change footwear, the
user simply removes the prosthetic ankle from one foot-shoe combination and connects it to another,
without the need for tools or modifications to the prosthetic alignment. This new prosthesis system
dramatically improves footwear options for persons using leg prostheses, enabling potential to increase
body image and community participation for women Veterans with leg amputations.
In this study, women Veterans with amputations will be recruited from a national sample to test the
modular ankle – 3D printed feet system. Informed consent and baseline measures will be collected
remotely. Women will then travel to the Minneapolis VA to be fitted with the novel prosthesis system
and shoes of their choice. Accommodation to the new prosthesis system will take place over several
days in Minneapolis with close clinical supervision. After returning home, women Veterans with
amputations will be followed remotely for a period of 6-months to track their outcomes. The study will
test the hypotheses that improving footwear options with our novel prosthesis will improve body image
and participation in women Veterans with amputations. Qualitative interviewing and photovoice will also
be conducted throughout the study to understand the benefits and barriers to using this new prosthesis
system.

Public health relevance
Veterans with leg amputations have limited footwear options because their artificial feet do not change shapes for different shoes. Studies have shown that women with amputations receive more frequent prosthetics care than men, but are less satisfied with the fit, comfort, and appearance of their prostheses. Our previous research indicates that women Veterans would like to be able to wear a broader variety of footwear, and those who perceive more footwear limitations tend to have poorer body image and community participation. A new prosthesis designed by our group allows Veterans with amputations to use their footwear of choice using 3D-printed artificial feet with a single ankle. Our novel prosthesis will be tested in this project with women Veterans with amputations to determine the impact of improving footwear options on body image and community participation.